ANALYSIS OF GROWTH FACTORS IN HUMAN CEREBROSPINAL FLUID

We have been testing for the presence of growth factors in the cerebral spinal fluid (CSF) of normal and schizophrenic human subjects. The test system uses neurite growth in cells from a neuroblastoma cell line (Neuro 2-A) to assay the presence of growth factors. Indirect growth factors that cause cells to secrete a diffusible growth substance have been demonstrated. However, the distribution does not discriminate between normal and schizophrenic subjects in specimens tested so far.